Immune activation and subject-specific risk in ocular gene therapies

Project summary
Gene therapies for heritable eye disorders are being developed at an unprecedented rate, but the immune
response, despite being a known reaction to gene therapies, is poorly characterized. Side effects to ocular gene
therapies do not affect individuals to the same degree clinically, despite receiving similar dosing and treatments,
underscoring the need for understanding subject-specific risk. In this proposal, I will 1) determine the effect of
immunosuppression on toxicity risks after intraocular gene therapy, 2) discover genetic variants that modify
susceptibility to gene therapy-related toxicity, and 3) test if subject-specific risks can be estimated before
treatment using blood. Genotype-phenotype correlations will be performed to map genetic loci associated with
toxicity phenotypes in mice with a diverse genetic background. To estimate risk specific to an individual animal,
biomarkers in blood will be measured and analyzed by machine learning. The overall objective of the research
is to use subject-specific characteristics to predict and mitigate toxicity risks. The long-term goal is to achieve
precision medicine via individualized risk assessment for ocular and for all gene therapies. Though the proposed
research uses mice as a model organism, the outcomes are highly clinically relevant and have immense potential
for making a positive clinical impact. The proposed work will advance personalized design and optimization of
ocular gene therapies.

Public health relevance
Project Narrative In this proposal, the effect of immunosuppression on ocular gene therapy toxicity is studied. Genetic variants that affect immune cell recruitment and gene therapy toxicity will be identified in mice, and the utility of a blood- based test in estimating an individual’s toxicity risk before gene therapy will be evaluated.